Administrative Core

Abstract
The primary purpose of this application, “Expanding Excellence in Developmental Biology in Oklahoma”
(Oklahoma Developmental Biology COBRE), is to strengthen our Developmental Biology Center at the
Oklahoma Medical Research Foundation and to prepare the Center and Cores for sustainability after COBRE
funding ends. In support of these goals, the Administrative Core will serve as the centralized coordinating
resource for the Oklahoma Developmental Biology COBRE and focus on the following Specific Aims:
Aim 1. To provide central management for the Oklahoma Developmental Biology COBRE components
and activities.
Aim 2. To provide mentoring for the Junior Investigators and assist with their transition to fully
independent status.
Aim 3. To form an External Advisory Committee of internationally recognized developmental biologists
to evaluate the progress of the Junior Investigators and provide advice.
Aim 4. To promote multidisciplinary approaches to research and interactions among the COBRE
investigators through a vigorous monthly seminar program.
Aim 5. To administer the Pilot Project Program
Aim 6. To facilitate interactions of the Oklahoma Developmental Biology COBRE with other COBREs
and with the national program.
Aim 7. To provide fiscal management of the COBRE and compliance with regulatory issues.
Aim 8. To promote data sharing strategies.